Modulation of AhR-dependent signaling by PPARb/d

The aryl hydrocarbon receptor (AhR) mediates increased expression of phase I and II xenobiotic metabolizing enzymes in response to exposure to chemical carcinogens including polycyclic aromatic hydrocarbons (PAH). We have discovered that peroxisome proliferator-activated receptor-[unreadable] (PPAR[unreadable]-also referred to as PPAR[unreadable]) may also alter AhR-dependent signaling by modulating cytochrome P450 (CYP) expression. In the absence of PPAR[unreadable]/[unreadable] expression, increased expression of CYP1B1 and CYP1A1 and some phase II enzymes does not occur after application of PAHs. Since there is a balance between bio-activation (phase I) and detoxification (phase II) of carcinogens that is mediated by AhR-dependent pathways, this suggests that PPAR[unreadable]/[unreadable] could significantly alter this balance. The central hypothesis of this proposal is that the PPAR[unreadable]/[unreadable] modulates the metabolic fate of PAH. We will determine the functional significance of PPAR[unreadable]/[unreadable]-dependent modulation of AhR-mediated signaling by testing the hypothesis that PPAR[unreadable]/[unreadable] modulates the balance between AhRdependent bio-activation and detoxification of PAH by examining the metabolic fate of PAH as well as oxidative DNA damage in mouse skin, primary keratinocytes;and verifying these changes in human keratinocytes.

Public health relevance
Principal Investigator/Program Director (Last, First, Middle): Peters, Jeffrey M. Lay relevance: The prevalence of cancer in the United States is associated with costs greater than $100 billion annually, and the causes of this disease are not entirely understood. It remains possible that exposure to chemical carcinogens contributes significantly to both cancer and toxicities. Thus, determining the mechanisms underlying chemically-induced disease is essential. The aryl hydrocarbon receptor is known to be required to mediate cellular changes that occur after exposure to chemical carcinogens (e.g. benzo[a]pyrene, etc). In these studies, we will examine whether a nuclear receptor can interact with this well documented signaling pathway and possibly identify novel target(s)/mechanisms that may modulate chemically-induced cancers. PHS 398/2590 (Rev. 09/04) Page Continuation Format Page